Development of Sensitivity to Acoustic Modulation in Infants who use Cochlear Implants

PROJECT SUMMARY/ABSTRACT
The ability of patients with cochlear-implants (CI) to discriminate speech sounds is the fundamental
measure of efficacy that clinicians use to create personalized clinical interventions. Given the universal
importance of early identification and treatment for children born with hearing loss, the most appropriate clinical
intervention for children with CIs should be initiated at the earliest possible age. Despite the routine
implantation of prelingually-deaf infants as young as 9-months-old, there are currently no established clinical
measures of CI efficacy for children younger than approximately 4-years-old. The long-term goal of the
proposed research is to develop new measures of device efficacy in cochlear-implanted infants that can be
used to drive clinical decisions at a much earlier age than is currently possible.
The ability to perceive patterns of temporal or spectral intensity modulation in a noise, or “acoustic
modulation perception”, is known to predict speech understanding in adult CI users. In previous work, the PI
adapted tests of acoustic modulation perception for testing infants and young children. The next step,
proposed in this application, will be to investigate how acoustic modulation perception develops, and relates to
speech perception, in implanted infants. This will involve examining the development of two independent
factors with markedly different trajectories: the ability to resolve the spectral place or timing of modulation, and
sensitivity to intensity modulation across frequency or time. The central hypothesis is that both normal hearing
and implanted infants will show an asymmetry in development of these factors. Frequency and temporal
resolution is expected to mature by 6-months postnatal hearing-age whereas sensitivity to intensity modulation
is expected to remain immature through 7-10 years old. The basis for this hypothesis is that frequency and
temporal resolution reflect early-developing peripheral auditory mechanisms whereas sensitivity to intensity
modulation reflects later-developing central auditory mechanisms.
There are 3 specific aims to this proposal. The first is to characterize the developmental trajectory for
frequency and temporal resolution in implanted and normal hearing infants during the first 6 months of post-
natal hearing experience. The second is to compare the developmental trajectory of spectral and temporal
modulation sensitivity in children implanted during infancy with that of normal hearing children through 10-
years-of-age. The third is to determine if frequency and temporal resolution independently predict speech
perception outcomes in implanted children. This work is a necessary step toward the goal of developing age-
appropriate, nonlinguistic measures of acoustic modulation perception that reflect CI efficacy in implanted
infants. If the long-term goal of the proposed research is realized, the positive impact will be to enable earlier,
more effective, clinical interventions for young patients who use CIs.

Public health relevance
PROJECT NARRATIVE Although many prelingually-deaf infants who receive a cochlear implant do not develop optimal auditory perception skills, clinical auditory speech perception tests are not administered until children are approximately 4 years old. The proposed research will investigate how perception of acoustic modulation, an important factor for speech understanding, develops in CI infants and how it predicts later speech perception. This work will help lead to clinical measures of device efficacy and auditory benefit for CI infants which will enable earlier, and more impactful, clinical interventions.